In vivo imaging of dorsal striatum function in freely behaving mice

Using our custom developed miniScope system, we imaged neuronal activity in dorsal striatum in freely moving mice, we also recorded mice locomotor activity, and compared neuronal activity to mice locomotor activity. We found that direct and indirect pathway neurons in the dorsal striatum displayed similar population activity. We further construct neuron cluster models based on our calcium recordings, and uncovered functional heterogeneity amount direct and indirect pathway neurons in dorsal striatum. Going forward, we will use this imaging technique to study how cocaine, THC and other substances of abuse alters dorsal striatum neuronal circuit function, and their contribution in the development of long-term drug addiction and relapse